Cellular and Molecular Mechanisms of Retinal Fibrosis

PROJECT ABSTRACT
Retinal neovascular disorders, such as retinopathy of prematurity and diabetic retinopathy, are the most
common causes of vision loss of working age adults and infants. Vascular endothelial growth factor
(VEGF) inhibitors have transformed the treatment of these disorders and resulted in improved outcomes
for millions of patients worldwide. However, regression of neovascularization often leads to deposition
of a fibrotic scar on the surface of the retina. These pre-retinal fibrotic scars can contract, resulting in
distortion of the retinal surface or detachment of the neurosensory retina. To date, surgery is the only
available intervention, often with poor visual outcomes. Despite the importance, very little is known
about the molecular mechanisms that regulate the formation of this pathological tissue, and there is
debate on the cellular source of fibrotic scar tissue in the retina. One of the main roadblocks for making
progress in this field is the lack of a robust and reproducible mouse model to study and manipulate pre-
retinal fibrosis, in order to decipher the key cellular and molecular mechanisms that regulate this
process. We have developed a novel mouse model of severe retinopathy of prematurity that develops
pre-retinal fibrosis subsequent to hypoxia driven neovascularization. Using histology and single cell
sequencing, our preliminary data indicates that the pre-retinal fibrotic scar results from pericytes that
upregulate collagen I expression following neovascularization. Here, we propose to further understand
the mechanism of pre-retinal scar formation by characterizing and manipulating this novel model. First,
we will fully characterize this model examining the time course of fibrotic scar formation, vaso-
obliteration, neovascularization, retinal inflammation, and visual function. Second, using lineage tracing
and single cell sequencing we will determine the identity the critical collagen I producing cells. Third,
we propose to test the hypothesis that activation of TGFβ signaling in pericytes is the key driver of pre-
retinal fibrosis. Our goal in understanding the cellular and molecular origin of retinal fibrosis is to
develop novel therapeutics to prevent blindness from traction in advanced ischemic retinopathies.

Public health relevance
PROJECT NARRATIVE Fibrosis associated with retinal neovascular disorders, such as retinopathy of prematurity and diabetic retinopathy, can result in severe visual morbidity. To date, the cellular and molecular origin of scar formation in these diseases is poorly understood, and surgery is the only available intervention, often resulting in poor outcomes. Here we propose to investigate a novel mouse model of hypoxia driven neovascularization that progresses to produce a fibrotic scar, providing an opportunity to identify the cellular identify and molecular pathway responsible for retinal fibrosis, with the goal of developing effective therapies to prevent this blinding process.